A framework enabling the genomic analysis of psychiatric traits across admixed populations.

PROJECT SUMMARY/ABSTRACT
Globally, neuropsychiatric disorders are the leading cause of disability. Despite recent advances in mental health
genetics in Eurasian groups, major limitations remain in the understanding of psychiatric disorders in minority
populations, in particular “admixed” groups of mixed ancestry. Due to the paucity of methodological approaches that
account for their additional genomic complexity, admixed populations are systematically excluded from psychiatric
genomic studies. Admixed populations, including African American and Latino individuals, make up more than a third
of the US populace and have higher rates of some anxiety disorders including PTSD, yet these groups face severe
disparities in mental health research and treatment due to being so sorely underrepresented in psychiatric genomics.
To reap full and equitable benefits from efforts including All of Us, NeuroGAP, and the PGC, there is a pressing unmet
need for the development of tools permitting the study of psychiatric traits in admixed peoples.
The candidate proposes to address this issue by developing a suite of statistical methods, software packages,
and analytical resources. Dr. Atkinson will: 1a) build a tool to allow for the integration of admixed individuals into
psychiatric GWAS; 1b) aggregate a significantly expanded Native American reference panel to improve genomic
inference in admixed American populations; 2a) characterize the genetic basis of traits relevant to psychiatric
disorders in diverse populations of the largest biobank dataset; 2b) leverage the linkage disequilibrium in admixed
individuals to improve fine-mapping; and 3) develop a statistical method that generates reliable genetic risk scores
for psychiatric traits in admixed subjects. These efforts fill a major gap in existing resources and will improve our
understanding of psychiatric diseases in diverse groups whom medical genomics has so far failed. These efforts are
in direct line with the strategic mission of the NIMH, highlighting the crucial and timely nature of the proposed project.
The proposed research and training plan were carefully designed to confer expertise in three domains: 1)
phenotypes and genetic architectures of psychiatric disorders, 2) statistical methods development, and 3)
professional development. These skills are fundamental to the candidate’s goal of becoming a leading investigator
who develops and applies statistical genomics to understand psychiatric disorders across diverse populations. In
addition to research training, Dr. Atkinson will take coursework, participate in regular seminars, attend workshops and
conferences, and gain mentorship and teaching experience locally and in Africa. All research will be conducted in the
Analytic and Translational Genetics Unit at Massachusetts General Hospital, the Broad Institute, and the Harvard TH
Chan School of Public Health with mentorship from renowned scientists Drs. Mark Daly and Karestan Koenen.
Additional guidance from leading experts Drs. Ben Neale, Alkes Price, and Jordan Smoller will ensure exceptional
guidance and support. Overall, the training environment is outstanding, the mentors and advisors are world-class,
the proposed studies address an urgent unmet need, and the additional skills gained in this award will poise Dr.
Atkinson to establish independent leadership in population, statistical, and psychiatric genomics.

Public health relevance
PROJECT NARRATIVE Psychiatric disorders are the leading global cause of years lived with disability and affect all societies, yet there are major disparities in mental health research and treatment across ancestry groups. Specifically, “admixed” people – those whose DNA contains more than one ancestral component, including African American and Latino individuals – are systemically excluded from studies due to the lack of available methods to appropriately handle their complex genomes. In this award, I propose to bridge this concerning gap in research space by developing novel methods and tools to enable the study of complex psychiatric traits in admixed people, bettering our understanding of mental health genetics in these diverse populations who have so far been underserved.